The Cause of Systemic Inflammatory Response during Cardiopulmonary Bypass and Prevention by Nitric Oxide

Abstract
Systemic Inflammatory Response and organ failure (SIRS-CPB) is a major problem following cardiac surgery.
The incidence increases with the amount of time on cardiopulmonary bypass. The mechanism is unknown. Our
preliminary studies indicate that white cell activation by surface exposure during CPB is the cause. Our studies
indicate that the white cell activation can be prevented by nitric oxide (NO) in the gas to the heart/lung machine.
This research is designed to determine the cause of SIRS-CPB and prevention with NO.

Public health relevance
Project Narrative Inflammation and organ failure is a common problem after cardiopulmonary bypass. This research will determine the cause of that syndrome and demonstrate prevention by nitric oxide.